Silybin as an anti-inflammatory and anti-fibrotic agent in cancer cachexia

Unintentional body weight loss (cachexia) in chronic diseases, such as cancer can lead to the
deterioration of quality of life, lack of response to treatment, and ultimately death. Cancer cachexia is
characterized by systemic inflammation, muscle and fat loss, and reduced physical function. Tissue
fibrosis or scarring has been observed in cancer cachectic patients. Muscle fibrosis is one of the most
consistent findings among people with reduced muscle function due to myopathies, neuromuscular
disorders, trauma, and sarcopenia. Blocking inflammation and fibrosis in the pre-cachectic and cachectic
stages is critical to positively impact muscle health, locomotion, and performance. Silybin, one of the
active compounds of the medicinal plant Silybum marianum has shown anti-inflammatory and anti-fibrotic
properties in cardiac and liver disorders. Since there are no approved therapies for cancer cachexia and
silybin has been associated to improve factors associated with cachexia, we propose to assess whether
silybin reduces skeletal muscle fibrosis. Furthermore, we will determine if TGF-􀈕 is involved in initiating or
maintaining loss of muscle mass and function. Our findings could lead to the discovery of a new
mechanism and novel strategies to prevent and/or treat cachexia.